Understanding initiation and progression of IPMNs in pancreatic cancer

Project Abstract
Pancreatic ductal adenocarcinoma (PDAC) is a deadly disease with a dismal survival rate at just 10%, largely
because most patients are diagnosed after the cancer has spread beyond the pancreas. PDAC is thought to
arise from two types of noninvasive precancerous lesions, namely, pancreatic intraepithelial neoplasia (PanINs),
and intraductal papillary mucinous neoplasms (IPMN), that develop in the ductal epithelium of the pancreas.
Here, IPMNs are large cystic neoplasms that are incidentally detected at increasing frequencies through
abdominal imaging. Comprehensive genomic analyses indicate that activating mutations in KRAS, GNAS, and
PI3KCA are associated with IPMN pathogenesis. Although genetically engineered mouse models (GEMMs)
have provided some insights into the development of IPMN, how IPMNs arise in humans in the context of
mutations that are exclusively found in IPMN lesions (GNAS and PIK3CA) and what cooperating events promote
progression to carcinoma is not understood. To address this question, we have developed a robust platform to
generate ductal and acini organoids from human embryonic stem cell (hESC)-derived pancreatic progenitor cells.
Using human exocrine pancreas, I have found that expression of GNASR201C in human ductal organoids
recapitulates several features of IPMN including lumen expansion, and secretion of mucins such as MUC2. This
study sets out to test the hypothesis that oncogenic GNAS promotes cell proliferation through PKA-independent
mechanisms in ductal cells and cooperates with other genetic events to promote initiation and progression of
IPMN lesions in vivo. Using a combination of cell biology, proteomics, and orthotopic transplantation approaches,
this proposal aims to identify mechanisms through which oncogenic GNAS differentially regulates cell
proliferation in ductal and acini pancreatic organoids (Aim1); and explore additional genetic events through which
oncogenic GNAS promotes formation of IPMN and IPMN-derived PDAC in the context of a physiologically
accurate tissue environment (Aim 2 and 3). The expected results will provide insights into the cell of origin for
IPMN lesions; identify mechanisms by which GNAS promotes early lesions; and establish models of IPMN-
derived PDAC, which may be exploited therapeutically in the long term to treat a broad range of IPMN-associated
tumors. The K22 award will allow participation in laboratory management, mentorship and grant writing
workshops, and enrolment in didactic courses, that will provide me with the necessary knowledge, resources
and training to (a) understand principles of omics research; (b) model cancer in mice; and (c) apply for additional
funding (R01) opportunities. Together with the support of my collaborators and establishment of an advisory
committee after obtaining a faculty position, my overall research, training and career development will help me
establish a unique niche in pancreatic cancer research as an independent investigator.

Public health relevance
Project Narrative In 10% of elderly patients, pancreatic ductal adenocarcinoma (PDAC) originates from mucin-producing cystic precancerous lesions called intraductal papillary mucinous neoplasms (IPMNs). Activating mutations in GNAS(R201C) are thought to drive IPMN-derived PDAC, but the cell of origin for IPMN initiation is not known. This proposal aims to take advantage of human stem cell-derived pancreatic ductal and acini organoids to understand how oncogenic GNAS supports initiation and progression of IPMNs in pancreatic cancer.